Optimizing blood PCR as test of cure in Chagas disease

Abstract
Infection with the protozoan parasite Trypanosoma cruzi is generally controlled but often not eliminated by host immune
responses. In humans and many other hosts, this persistent infection ultimately results in muscle tissue damage known
as Chagas disease. Although several partially effective drugs exist to treat the infection, it is estimated that only ~1% of
infected subjects receive treatment. The major impediment to the wider use of current drugs, the development of better
therapeutics in Chagas disease, and the identification of those who would benefit from treatment and the success of
treatment in those individuals, is the absence of reliable methods to definitively determine the presence or absence of
infection. Diagnosis of possible infection is generally achieved using a combination of serological tests, which are reliable
for detecting prior exposure but provide limited information on whether the infection is active. The goal of this project is
to validate and improve PCR-based tests of cure for T. cruzi infection. The primary application of the results of this study
will be to the more definitive evaluation of clinical trial outcomes. Current PCR-detection protocols for diagnosis of T.
cruzi infection generally use a very limited (sometimes only one) blood sample and assay a single aliquot from that
sample. However, subjects in trials of anti-T. cruzi drugs are generally bled multiple (4-6) times post-treatment and 1-3
aliquots are submitted to PCR, usually with variable results between bleeds and aliquots. The hypothesis underlying the
proposed work is that definitive detection of infection via PCR of parasite DNA in blood can be achieved by increasing the
sampling of blood, both the number of blood samples taken and the aliquots of that blood that are evaluated by PCR.
This hypothesis will be tested in a group of naturally infected rhesus macaques who will be repeatedly sampled over
both an extended time frame (1 year) and a more limited period (1 month) with up to 200 aliquots of DNA screened by
PCR at each bleed point. Parallel studies using parasite- or parasite-DNA-spiked blood we allow interpretation of the
blood parasite levels in the infected animals, and its variation, over months or years. The ultimate outcome of these
studies is expected to be a dependable pre-enrollment protocol for participant selection for clinical drug trials and
definitive tests at the conclusion of such trials that unequivocally measure treatment efficacy. Such tools will assure that
future clinical trials of candidate anti-T. cruzi drugs will provide conclusive results.

Public health relevance
Project Narrative Chagas disease (American trypanosomiasis) is the highest impact infectious disease in Latin America and a growing threat in the United States. A key factor preventing use of current drugs and the development of safer and more effective new drugs is the low level of parasites in the blood of infected subjects, which makes discrimination of an active infection from a resolved (cured) infection, difficult. The goal of this project is to enhance the current parasite detection protocols by determining the optimal blood sampling frequency that provides a definitive conclusion on infection status.